Developmental Core

ABSTRACT, DEVELOPMENTAL CORE
The B-HIVE Developmental Core leverages the successful, multimodal approach used in HIVE Center, with
several overarching goals: to streamline B-HIVE Center research and training, and to share the results of HIV
research with scientists, educators, students, and the general public. Developmental Core efforts will include a
Collaborative Development Program to bring new functionality into B-HIVE, presenting and disseminating
training programs targeting researchers and new scientists at all levels, a nimble website to streamline
communication inside and outside of B-HIVE, and creation of dynamic materials for education and outreach. All
developmental efforts will be designed and implemented with a strong focus on building diversity within the B-
HIVE Center and in the larger research community. Co-leads Karen A. Kirby and David S. Goodsell will perform
all activities for the Developmental Core, directed by the Administrative Core and in close collaboration with the
Projects and Scientific Cores.
Aim 1. Developmental Core Organization and Administration. Policies and procedures are outlined for the
Developmental Core.
Aim 2. B-HIVE Collaborative Development Program (CDP). The CDP will provide support for 2-3 innovative
investigators per year to provide new, synergistic methodologies to the B-HIVE Center community.
Aim 3. Professional Training. Training activities will include a biannual Professional Trainee Retreat Program,
and leverage of existing high school, undergraduate, graduate, and postdoctoral internship/fellowship programs
available at B-HIVE member institutions.
Aim 4. Community Outreach. This will include developing and maintaining the B-HIVE Center website, which
will provide a multimodal approach to dissemination of B-HIVE Center results, and an intranet for communication
among the B-HIVE Projects and Cores. Outreach efforts will also utilize a dynamic program of infographics and
online features to educate scientists and non-specialists about HIV biology and research from B-HIVE and inspire
a new generation of HIV researchers.
Aim 5. Building Diversity in B-HIVE Center Researchers. The Developmental Core, in collaboration with the
Administrative Core, will manage B-HIVE Center efforts to promote a diverse, open, and inclusive B-HIVE
research environment, to recruit, retain, and develop a diverse B-HIVE research community, and to assess B-
HIVE Center efforts to build diversity.